Early clinial trials for Angelica herbal supplements for prostate cancer interception

PROJECT SUMMARY
The slow growing nature of most prostate cancers (PCa) provides multiple windows of opportunity to block or
delay disease progression to significantly reduce patient suffering and mortality. This is especially true following
the failure of radical prostatectomy (RP) and radiation therapy (RT) of PCa prior to androgen deprivation therapy
(ADT; i.e., medical or surgical castration). Biochemical recurrent PCa is sensitively indicated by rising blood
prostate specific antigen (PSA). ADT is not curative and causes many serious adverse effects. Our goal is to
develop Angelica gigas Nakai (AGN, Korean Angelica) root ethanolic extract or its constituent(s) as a safer and
practical modality for PCa interception akin to secondary prevention to delay ADT or avoid it entirely. We
hypothesize that (1) the PCa interception efficacy of AGN and its pyranocoumarins in animal models is
extendable into human PCa patients, given sufficient AGN dosage and exposure duration; (2) multiple
mechanisms including immune surveillance and suppression of inflammation contribute to the clinical cancer
interception activity. The scientific premise is based on the presence of novel active pyranocoumarin compounds
distinct from those in soy, tea, fish oil, raspberries, mushrooms, and cannabis and reported broad spectrum anti-
cancer efficacy in animal cancer models. Moreover, we have demonstrated a) Oral bioavailability and favorable
pharmacokinetic (PK) metrics in rodents and in humans; b) Cytochrome P450 (CYP) 2C19 and 3A4 first-pass
conversion of pyranocoumarins decursin (D) and decursinol angelate (DA) to their metabolite decursinol (DOH);
c) Proficient tissue retention of decursinol in mouse target prostate; d) Animal modeling of AGN and decursinol
showing independence of the androgen receptor axis, avoiding side effects of ADT drugs and making blood PSA
a reliable readout for cancer burden; e) AGN enhanced immune and decreased inflammatory gene signatures
in an animal PCa model; and f) A single AGN dose in human subjects increased natural killer [NK] mRNA
signature and decreased IL-8 chemokine mRNA in their peripheral blood mononuclear cells. We propose 3
specific aims in post-RP and post-RT patients with rising plasma PSA that is “clean” (due to prostate already
removed) and indicative of the biochemical recurrent PCa burden. Aim 1. Characterize pyranocoumarin PK dose
response proportionality to AGN supplement and food effects in 12 patients to probe any metabolic ceiling and
minimize food-herbal interaction. Aim 2. Evaluate safety and recurrent PCa (PSA)-interception efficacy of twice
daily AGN supplement in a Phase I/II trial with 36 patients. Aim 3. Measure acute- and repeated-dose PK metrics,
CYP 2C19 and 3A4 metabolizer status and changes of immune and inflammation biomarkers to correlate to PSA
outcomes. Impacts: The safety information and a favorable PSA response will guide future randomized control
trials to prevent or treat PCa and other cancers. The novel knowledge on PK dose response, repeated dose PK
behavior, CYP pharmacogenetics and the immune biomarkers not only fills in critical gaps for AGN supplements
in cancer patients, but also is exportable to disease prevention and therapy beyond oncology.

Public health relevance
Narrative These early stage clinical trials take advantage of a niche prostate cancer patient cohort who have failed local “curative” therapies to address a significant unmet clinical need in a sizable recurrent cancer patient population who would otherwise soon face androgen deprivation therapy (ADT) through medical or surgical castration. Not only expensive, ADT also causes many serious and unpleasant side effects including sexual dysfunction/impotence, osteoporosis and bone fractures, mode swings, hot flashes, fatigue, loss of lean body mass, gynecomastia and anemia. In spite of multiple next-gen androgen and its receptor targeted drugs (e.g., abiraterone acetate, enzalutamide), DNA-repair drugs (PARP inhibitors) and microtubule targeting taxane drugs indicated for managing more advanced stage diseases, there is currently no FDA-approved modality before ADT to intercept or delay disease progression in the clinic practice. The trials will provide the first of its kind knowledge of safety and preliminary efficacy of an AGN herbal supplement against prostate cancer at therapeutic dosages, with mechanisms of action distinct from the currently approved drugs and more favorable safety profiles. The novel dose-exposure pharmacokinetics and pharmacogenetics information from these trials will be applicable to other patient populations to evaluate prevention and therapy of other cancers as well as other diseases since AGN supplements have been sold for memory health and pain killing for nearly 2 decades.